Project 1 - Integrating targeted and immune therapies for BRAF mutant colorectal cancer

Project Summary
BRAF inhibitors lack efficacy in BRAF mutant (BRAFm) CRC (response rate only 5%) in contrast to
response rates of >50% in BRAFm melanoma. Key studies conducted as part of our prior SPORE project
identified feedback networks present in CRC (but absent in melanoma) that lead to rapid reactivation of
MAPK signaling following BRAF inhibition, as primary drivers of resistance. This critical discovery led to
clinical trials of BRAFi-based therapeutic combinations designed to block MAPK reactivation, resulting in
an increased response rate for BRAFm CRC patients from 5% to >30%. Despite these therapeutic
advances, clinical benefit is not durable, with a median PFS of only 4-5 months. Here we will explore
potential cooperativity between targeted MAPK inhibition (MAPKi) and immune checkpoint blockade
(ICB) to convert less immune responsive tumors to more immunogenic tumors. BRAFm CRC represents
a prime population for exploring potential cooperativity, as 20-30% of metastatic BRAFm CRCs harbor
MSI, which confers responsiveness to ICB. Moreover, we have observed durable responses of >5 years
in MSI BRAFm CRC patients receiving MAPKi alone. In MSS BRAFm CRC patients, we see marked
induction of CD4+ and CD8+ T-cells with MAPKi alone in paired tumor biopsies, and our preclinical
mouse models demonstrate a cooperative effect of MAPKi and PD-1 IC in MSS BRAFm CRC. We
propose a comprehensive effort using innovative immune competent BRAFm CRC mouse models,
cutting-edge molecular and immune analyses of paired pre- and on-treatment tumor biopsies, and novel
clinical trials to explore combined MAPKi and ICB as a strategy to achieve durable benefit in BRAFm
CRC patients. Aim 1 will define the effects of MAPKi alone and with PD-1 ICB on immunogenicity of
BRAFm CRC and anti-tumor immunity using immunologic and transcriptional profiling approaches to
analyze novel BRAFm CRC models and a unique collection of paired pre-treatment and on-treatment
biopsies from BRAFm CRC patients given BRAF/EGFR/MEKi. Aim 2 will conduct clinical trials and
correlative studies of novel immune and targeted combinations for BRAFm CRC, evaluating clinical
efficacy of combined BRAF/MEK/PD-1 inhibition. We will collaborate with the Pathology Core for
multiplexed immune analysis of tumor biopsies, and the Biostats Core for analysis of bulk and single cell
RNAseq and whole-exome sequencing. These studies will provide key insights to guide design of future
trials. Aim 3 will define mechanisms of response and resistance to combined MAPKi and ICB in BRAFm
CRC mouse models, and test strategies to overcome resistance to MAPKi/anti-PD-1 using combined ICB
and modulators of immunosuppressive mechanisms defined by our analyses in Aims 1 and 2. These
studies will define the potential synergy between MAPKi and ICB in BRAFm CRC and mechanisms of
response and resistance to establish a new therapeutic paradigm for this lethal CRC subtype

Public health relevance
Project Narrative Project 1 will determine effectiveness of MAPK-targeted therapy combined with anti-PD-1 for BRAFm CRC patients using immune competent BRAFm CRC mouse models and tumor biopsies from BRAFm CRC patients to define effects on tumor immunogenicity and immune response, identify patients most likely to benefit, and identify novel candidate targets to combine with MAPKi and anti-PD1 based on RNAseq data.